Proteasome Inhibitor-Loaded Antibody Drug Conjugates with High Drug Loading For Targeted Treatment of Triple Negative Breast Cancers

Project Summary/Abstract
Proteasome inhibitors (PIs) are one of the most important classes of therapeutics to have
emerged in the past two decades and now serve as the backbone of multiple myeloma (MM)
treatment. The first-in-class PI, bortezomib (Btz), targets the ubiquitin proteasome pathway
(UPP), which has led to tremendous efficacy in inducing plasma cell apoptosis and in inhibiting
MM growth. Despite the universal nature of PI as a mechanism of action (MoA) and strong
preclinical results, the clinical use of the PIs bortezomib, ixazomib, and carfilzomib for solid cancer
indications have been largely unsuccessful thus far due to significant dose-limiting toxicity (DLT)
and exceedingly narrow therapeutics window. As the entire solid cancer patient population is
treatment-naïve to PIs, technologies that can deliver Btz in a targeted manner, thereby
circumventing its DLTs, would be highly desirable especially in recalcitrant indications such as
triple negative breast cancer (TNBC).
We have developed a novel Antibody Drug Conjugate (ADC) platform that enables controlled
drug release of a covalently conjugated PI in targeted cancer cells. Additionally, our ADC platform
has drug loadings multi-fold higher than what is used in state-of-the-art FDA approved ADCs like
Enhertu® and Trodelvy®. Thus far, we have shown in a low HER2 breast cancer model that an
iteration of our PI-loaded ADC can outperform T-Dxd, a biosimilar of Enhertu.
Over 12 months, we intend to synthesize and characterize a library of these PI-loaded ADCs
with varying targets and drug loadings. By use of in vitro screening of their binding affinities,
cellular internalization, and potency, we will screen this library for best performing candidates.
Further in vivo PK/BD and efficacy studies in various low-expression TNBC mouse models will
enable us to find an optimal PI-loaded ADC lead candidate to push forward. Success of this
project will be determined by the discovery of at least one WTx-ABC lead candidate that can be
further developed for clinical application with a Phase II SBIR.

Public health relevance
Project Narrative We aim to demonstrate proteasome inhibition can be a useful therapeutic mechanism of action against solid cancers through the active targeting of a new class of Antibody Drug Conjugates (ADCs). By use of our novel brush polymer architecture, we have created an ADC platform that allows for precisely controlled drug release and drug loadings multi-fold higher than the current state-of-the-art FDA-approved ADCs like Enhertu® and Trodelvy®. Over the course of this project, we will screen a library of these novel ADCs to find an optimized lead candidate for the treatment of Triple Negative Breast Cancer.